Microenvironmental regulation of breast tumorigenesis

PROJECT SUMMARY
Breast cancer susceptibility gene 1 (BRCA1) is a tumor suppressor gene best known for is function in DNA
repair. Early studies suggested that genome instability within the mammary epithelial system of BRCA1
mutation carriers (BRCA1+/mut) promotes a cascade of cell autonomous, genetic events ultimately giving rise to
cancer initiation within a population of luminal epithelial progenitor cells. However, a major gap in knowledge is
whether germline BRCA1 mutations lead to cell state aberrations within the cellular microenvironment
surrounding the epithelium, which may act in trans to promote pre-cancerous changes in the epithelial system
thereby promoting breast cancer initiation.
In this renewal, we will expand on the provocative findings from our currently funded project, which
identified dramatic precancerous changes in both breast epithelium and surrounding microenvironment of
human BRCA1+/mut. Our work identified the expansion of epithelial cells with basal-luminal intermediate (BLI)
phenotype as well as a population of epithelium-surrounding precancer-associated fibroblasts (preCAFs)
expressing copious amounts of matrix metalloproteinase 3 (MMP3) and immunoregulatory factors (e.g.,
neutrophil-attracting CXCL8). Based on our progress and preliminary data, we will address the hypothesis that
preCAFs emerge in a cell-intrinsic manner due to fibroblast-specific BRCA1 deficiency leading to an aberrant
form of fibroblast differentiation. In this context, we will test whether cell-intrinsic NFkB activation in BRCA1+/mut
acts as a central signaling node towards the preCAF state. We will also determine whether BRCA1mut
fibroblasts establish a precancerous immunosuppressive microenvironment during breast cancer initiation
through MIP-2, a mouse homologue for CXCL8. Addressing these major gaps in knowledge about the function
and origin of preCAFs may pave the way towards novel therapeutic approaches to block the cancer-promoting
function of preCAFs or reverse their phenotype as precision cancer prevention strategies.

Public health relevance
PROJECT NARRATIVE Breast cancer arises from breast epithelial cells that gather pro-tumorigenic mutations leading to uncontrolled cell proliferation and tumor initiation. Knowledge of how tumor initiation can be regulated by the cellular microenvironment will enable us to specifically interfere with the function of tumor-initiating cells to stop tumor growth and potentially recurrence of breast cancer. In this renewal, we will explore the emergence precancer-associated fibroblasts (preCAFs) and define their role in reshaping the breast immune microenvironment in the pre-malignant breast of BRCA1 mutation carriers. This may ultimately lead to the development of novel therapeutic approaches for primary cancer prevention and to treat patients suffering from breast cancer.